Leadership and Administrative Core

REVISED ABSTRACT: Alzheimer’s disease (AD) is a major and increasing public health crisis in the United States (US) and a growing health problem.1, 2 We seek to build on the experience of an interdisciplinary team in AD/ADRD-relevant research to support early career researchers and mid-career scientists newly transitioning into AD/ADRD-relevant research carrying out research of high quality intended to prevent cognitive and functional decline in older adults from different social and economic groups and reduce variations across groups in incidence of AD/ADRD. The faculty of this AD-RCMAR are from the Johns Hopkins Schools of Public Health, Nursing, and Medicine, Morgan State University, and North Carolina A&T University and have decades of experience working with older adults from different backgrounds, and the community organizations that serve them. All are nationally recognized mentors with substantial experience training early career scholars. The overall aims for this renewal application of the Leadership and Administrative Core (LAC) are to provide governance and administration of the Center, to facilitate the training and development of RCMAR Scientists, and to advance the field of research on aging on different social and economic groups on AD/ADRD. The LAC will provide essential leadership and structure for this AD-RCMAR and its mentoring, data collection, analysis, analysis, intervention, implementation, and dissemination activities, providing coordination and integration across the Cores and Pilot Studies, while maintaining communications with other NIA Research Centers, and external funding and oversight entities. The LAC will work closely with the Research Education Component, Community-Liaison and Recruitment Core, and the Analysis Core to accomplish these aims, thereby advancing our understanding of social and behavioral aspects of aging from different social and economic groups to ameliorate variations across groups relevant to AD/ADRD. The MPI’s (Drs. Thorpe and Gallo) will be responsible for oversight of all Center activities to ensure accountability and responsiveness to evolving scientific opportunities and public health needs, including quality control of research, protection of human research participants, supervision of administrative functions, fiscal oversight, interfacing with the External Advisory Committee, and liaison with grant agencies and officials of Johns Hopkins University and participating Centers and Universities.